Research Centers in Minority Institutions (RCMI) Coordinating Center

PROJECT SUMMARY/ABSTRACT
The overall objective of the proposed RCMI Coordinating Center (RCMI CC) is to serve as a national
resource to advance the science of minority health and health disparities across the RCMI U54 Centers
through coordination of intellectual exchange and collaborative interactions that enhance research capacity
and competitiveness. To achieve this objective, the RCMI CC will engage the RCMI U54 PI/PDs and Core
Directors for research infrastructure, investigator development, and community engagement, as well as
develop a robust evaluation and tracking plan.
Specific Aim 1. Coordinate program administration and evaluation across the RCMI U54 Centers
Approach: Organize and convene an annual face-to-face RCMI grantees conference; convene monthly
meetings of the RCMI U54 PI/PDs to discuss administrative issues and program evaluation; coordinate and
enhance communication, marketing and outreach activities; develop common performance metrics.
Specific Aim 2. Coordinate and leverage research resources to support scientific projects
Approach: Convene monthly meetings of the U54 RCMI Research Infrastructure Core (RIC) Directors to
discuss core facility management, sharing specialized equipment and other resources, researcher needs and
research barriers; facilitate broad access to other non-RCMI research resources; provide methodology
consultations; maintain a centralized database to track performance metrics.
Specific Aim 3. Coordinate mentoring and career development of new and early-stage investigators
Approach: Convene monthly meetings of the U54 RCMI Investigator Development Core (IDC) Directors to
discuss mentoring strategies and best practices for pilot projects programs; facilitate broad access to and
facilitate collaboration with RCMI and non-RCMI investigators.
Specific Aim 4. Coordinate sustainable engagement with community organizations and partners
Approach: Convene monthly meetings of the U54 RCMI Community Engagement Core (CEC) Directors to
discuss best practices for community engagement; facilitate broad access and collaboration with RCMI and
non-RCMI community partners; foster sustainable relationships with community-based organizations.
Based on our previous experience of successfully administering the RCMI Translational Research
Network, the expectation is that the proposed RCMI CC will have a significant impact on improving
coordination and communication across the RCMI U54 Centers.

Public health relevance
PROJECT NARRATIVE The proposed RCMI Coordinating Center will serve as a national resource to advance the science of minority health and health disparities through coordination of intellectual exchange and collaborative interactions that enhance research capacity and competitiveness of the RCMI U54 Centers.